Learning the Regulatory Code of Alzheimer's Disease Genomes

Project Summary Alternative splicing is a key cellular process whose dysregulation has been implicated broadly across human genetic disease. Dr. Knowles previously developed LeafCutter, a flexible, scalable, annotation-free tool to quantify local patterns of RNA splicing from short-read RNA-seq data. While LeafCutter has been quite widely adopted and we have actively maintained it and addressed issues on github, it remains “early stage” software. We propose software engineering improvements: 1) appropriate packaging using conda with standard build, installation, testing and logging processes, 2) containerization using Docker, 3) standardization of input/output data formats/interfaces, and 4) refactoring to use a standard workflow language. These improvements will allow us to distribute LeafCutter through repositories including PyPI, BioConda, DockStore, and Galaxy. Finally improvements to documentation, testing and version management will make contributions to LeafCutter from the open source community more feasible and easier to integrate. The parent award for the proposed work is U01 AG068880-01 “Learning the Regulatory Code of Alzheimer's Disease Genomes”, where we are developing state-of-the-art deep learning (DL) and machine learning (ML) models to better understand the genetic basis of AD. This award makes extensive use of LeafCutter. In Aim 1 we are building DL models of pre- and post- transcriptional regulation: for the latter LeafCutter provides training data for our neural network model of the sequence determinants of RNA splicing in AD-relevant cell types and states. In Aim 2 we connect AD-associated structural variation to functional variation, including RNA splicing variation. In Aim 3, we will build trans-expression QTL networks across thousands of post-mortem brain samples: with the improvements to the LeafCutter ecosystem proposed here we will be able to straightforwardly extend to trans splicing QTL networks. While we and our collaborators are ourselves heavy users of LeafCutter, we will continue to ensure we provide for the needs and use-cases of the broader genomics community.

Public health relevance
Alternative splicing is an important cellular process where “junk” DNA is removed from the gene before it is translated into protein. When this process is disrupted in some way it can cause disease. Here we propose software engineering improvements to software, LeafCutter, we previously developed to better understand splicing patterns from RNA-seq data.